The role of heparan sulfate in cathepsin K biology

Excessive osteoclast activity underlies many bone diseases such as osteoporosis, periodontitis, rheumatoid
arthritis and Paget’s disease. Bone resorption requires degradation of organic bone matrix, whose main
component is type I collagen. To degrade bone matrix, osteoclasts secrete cathepsin K (CtsK), a potent
collagenase that functions optimally under acidic pH. CtsK-null mice display severe osteopetrotic phenotype
despite normal differentiation of osteoclasts, which strongly supports the essential role of CtsK in bone
resorption. A highly positively charged protein, CtsK is known to bind negatively charged glycosaminoglycans,
among which it binds heparan sulfate (HS) most avidly. Widely distributed at the cell surface and in the
extracellular matrix, it is conceivable that the high-affinity interaction between CtsK and HS plays a role in CtsK
biology. However, how HS regulates the biological functions of CtsK remains completely unknown. The
persistence of this critical knowledge gap prevents us from gaining a more complete understanding of CtsK
biology, and likely also from fulfilling the therapeutic potential of targeting CtsK. Our central hypothesis is that
heparan sulfate regulates the activity and localization of CtsK, and that CtsK activity can be
manipulated by targeting its HS-binding site. Guided by strong preliminary data generated in the lab, our
hypothesis will be tested by pursuing the following three specific aims. Aim 1: Determine the structural
details of CtsK-HS interaction. We will employ complementary biophysical/biochemical methods including
X-ray crystallography, small-angle X-ray scattering and HS oligosaccharide microarray to understand the
structural basis of CtsK-HS interaction. Aim 2: Determine the biological roles of CtsK-HS interaction. By
utilizing a newly generated knock-in mouse strain bearing an HS-binding deficient CtsK (CtsK∆HS), we will try to
understand the physiological consequence of disrupted CtsK-HS interaction. Aim 3: Inhibition of CtsK with
structurally defined HS oligosaccharides. We will examine the antiresorptive activity of CtsK-binding HS
oligosaccharides in a number of murine models of bone remodeling. By investigating CtsK-HS interaction using
a combination of in vitro and in vivo methods, our contribution will be significant because we will identify
multiple mechanisms by which HS regulates the biological functions of CtsK. Without this critical knowledge,
our understanding of CtsK biology will never be complete. The outcome of our investigation could also help
design novel ways of manipulating the activity of this highly important protease. In particular, because HS
possesses the unique property of selectively inhibiting the collagenase activity of CtsK without compromising
its normal peptidase activity, our investigation might help develop an ideal CtsK inhibitor for treating many bone
diseases.

Public health relevance
The proposed research is relevant to public health because understanding of the basic biological function of heparan sulfate–cathepsin K interaction is ultimately expected to provide novel therapeutic solutions to treat many diseases associated with undesired bone resorption. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to seeking fundamental knowledge that will help to reduce illness and enhance health.